Core B. Clinical Translational Core

PROJECT SUMMARY – CLINICAL TRANSLATIONAL CORE
The present application seeks funding to continue the MIND Institute Intellectual and Developmental
Disabilities Research Center (IDDRC) at the University of California, Davis. The IDDRC was launched in 2013
and is the newest of the 14 IDDRCs in the network. The Clinical Translational Core (CTC) is designed to establish
and maintain an operational framework that is optimal for recruitment, diagnostic assessment, neurobehavioral
characterization, and mapping of phenotypes to underlying biological mechanisms for a diverse range of clinical
populations. The CTC will address five specific aims. Aim 1 is to enhance recruitment of a diverse range of
participants. This aim will be met through systematic community engagement and a growing participant registry
that includes multiple ethnicities, races, and economic backgrounds with both atypical and typical populations
across a wide age span. Aim 2 is to provide behavioral and diagnostic characterization of human participants.
This aim will be met by providing access to experienced clinicians who can conduct specialized evaluations,
advise studies in best practices, provide training in administration of standardized measures, establish initial
reliability, and monitor administration fidelity, as well as by providing access to specialized testing space and
connect investigators with clinical trials expertise. Aim 3 is to provide access to state-of-the-art “deep
phenotyping” tools and expertise in genomics. This aim will be met by offering tools and training to enhance
phenotypic characterization of participants, making available recent innovations in deep phenotyping and
genomics to IDDRC investigators. Aim 4 is to support the integration of technology into research, especially
telehealth methodologies that can lead to scalable, accessible, and cost-effective treatments for IDD conditions.
This aim will be met by providing on-site high-level research IT support and access to the full array of
technologies and expertise at UC Davis Health. Aim 5 is to facilitate collection and analysis of biospecimens
from human participants and promote sharing across IDDRC projects. This aim will be met by providing
phlebotomy services and access and incentives to use a core-managed freezer library for biospecimen storage
as well as by links to the MIND IDDRC Biological and Molecular Analysis Core and the MIND Institute Genomic
Medicine Program. The proposed CTC has been significantly expanded relative to the previous funding period,
with the most significant change being the integration of the deep phenotyping and measure dissemination
functions of the previous Neurobehavioral Analysis Core, which has led us to rename this expanded core, the
CTCx. The Director of the CTC is Sally Ozonoff, PhD.